Roybal Center for Fearless Behavior Change - renewal Administrative Core

The goal of the Columbia Roybal Center for Fearless Behavior Change is to advance behavioral
interventions that reduce psychological distress and improve health behaviors in midlife and older adults that
experience serious health events. Each year, millions of adults experience events such as heart attacks,
strokes, or life-threatening cancer diagnoses. For some, these events serve as a wake-up calls, or “teachable
moments,” and those patients acquire health behaviors that prevent recurrent events and slow disease
progression. Yet, many of these patients are highly distressed after these events, leading to substantial impact
on quality of life, health behaviors, and prognosis. For example, 1 in 3 patients develop PTSD symptoms after
cardiac arrest and critical illness, and 1 in 5 patients develop persistent depressive symptoms after heart
attacks. Those patients who are highly distressed are less likely to follow recommended health behaviors such
as taking medications, exercising, and having good sleep. We have shown that many patients avoid
medications because they are reminders of disease risk, and exercise because physiological changes (e.g.,
heart rate) are frightening reminders of the possibility of a recurrent event. Accordingly, our Roybal Center is
interested in advancing interventions that target these fear-based mechanisms for which interventions are
underdeveloped. There are already evidence-based interventions for reducing other common forms of
psychological distress after serious health events such as anxiety and depression. Our Center also aims to
conduct implementation research that accelerates the adoption of these effective interventions into practice.
Our Center's Administrative Core will support and facilitate the administrative management of the proposed
Center, as well as the coordination of clinical trial selection via a national competition; financial and regulatory
oversight of trials; maintenance of Common Evaluation Metrics including those relevant to DEIA in the make-
up of scientific teams and recruitment/retention of participants; engagement with key stakeholders;
communication within and between Roybal Centers and clinical trial scientists; and dissemination of scientific
products. This Core will collaborate with the Stress Measurement Network and Science of Behavior Change
program to ensure robust measurement of behavioral mechanisms in all trials. It will also convene an External
Advisory Committee comprised of scientific experts in the conduct of behavioral trials and patient stakeholders
that will review and prioritize applications for new trials to the Center as well as provide strategic advice on the
overall conduct of the Center. This Core will remain in close communication with the Behavioral Intervention
Development Core that provides implementation science, regulatory, and statistical support to trialists, and is
responsible for conducting clinical trials in our Center. Together, these Cores will ensure the efficient and
successful conduct and dissemination of rigorous behavioral trials with the potential to improve the well-being
and prognosis of midlife and older adults who experience serious health events.